PHASE I/II TRIAL OF SDZ MSL-109 IN PATIENTS WITH AIDS AND CMV VIREMIA/VIRURIA

A phase I/II trial to determine the optimum dosage, pharmacokinetics, and toxicity profile of a human monoclonal antibody directed against human cytomegalovirus.